Protein-RNA Interactions

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Protein-RNA Interactions, organized by Drs.
Gene Yeo, Wendy Gilbert and Lori Passmore. The conference will be held in Vancouver, Canada from
January 29- February 1, 2023.
Ribonucleic acid (RNA) binding proteins (RBPs) are a major category of regulators encoded by more than two
thousand human genes. Over the last few years, millions of protein-RNA interactions in a myriad of cellular
contexts have been measured by increasingly scalable technologies, providing opportunity for deeper
connections with genetics and disease. In parallel, stunning breakthroughs in microscopy and structural
methods have revealed fundamental insights into protein-RNA interactions. This conference addresses
growing excitement from both the basic and translational life sciences community in imagining protein-RNA
interactions as a treasure trove of new biology and drug targets. This conference is unique in that it will
provide a forum to assemble multi-disciplinary leaders in various themes in the RNA community to cross-
fertilize emerging ideas in fundamental protein-RNA science. Other sessions will introduce a diversity of
newcomers to the newest methods and results in the field and introduce and identify new targets and
modalities for therapeutic opportunities. Finally, this conference will be held jointly with the Keystone
Symposia conference on Biomolecular Condensates which is a natural collaboration as RNA binding proteins
play major roles in condensation of protein-RNA/DNA interactions. Participants at both conferences will be
able to network and develop new collaborations through shared sessions and meals.

Public health relevance
PROJECT NARRATIVE Ribonucleic acid (RNA) binding proteins (RBPs) play a major role in the regulation of gene expression and are associated with a number of genetic disorders. This conference will bring together scientists working across the diverse field of RNA-protein interactions to discuss the latest advancements in the field. In order for the research in the field to move forward, investigators will need collaborative sharing of the newest technologies with the newest modalities for therapeutic intervention as provided by this conference.